Gene expression changes during postnatal development of the marmoset, mouse, and human brain: a pilot study with focus on prefrontal cortex,adolescence, and psychiatric risk genetics

PROJECT SUMMARY
The adolescent brain undergoes dramatic changes in both structure and function. Human imaging, structural,
and genetic data suggest a developmental trajectory that extends through the second into the third decades of
human life. Neuropsychiatric conditions such as schizophrenia and mood disorders typically emerge during this
period and are believed to arise due to the interplay of genetic predispositions, environmental insults, and the
long-term maturation of the adolescent brain. The prefrontal cortex undergoes a particularly extended maturation
through adolescence, is critical for higher cognitive functions disrupted in psychiatric disorders, and is the primary
site of proposed pathological hallmarks of schizophrenia, including decreased synaptic density and gray matter
volume. To test mechanistic hypotheses of genetic and environmental factors impacting prefrontal development,
we must invest in tractable animal models with the highest potential for clinical relevance. The common
marmoset, a platyrrhine non-human primate, represents the next frontier in neurological therapeutics research.
Their small stature, short gestation period, ease of handling and ability to be genetically modified have put them
at the forefront of neuropsychiatric disease modeling. In this proposal, we aim to produce a comprehensive
genetic dissection of the marmoset prefrontal cortex across childhood through adolescence to adulthood.
Furthermore, we will take a major step to validate and enable the use of marmoset in neuropsychiatric research
by integrating our findings across species and with identified genetic risk factors for schizophrenia and other
neurodevelopmental disorders. Combining expertise in comparative neuroanatomy, single-cell and spatial
transcriptomics, and bioinformatics, our collaborative team will identify developmental changes across all frontal
cortical areas, cell types, and molecular pathways. Together, these experiments will provide a foundation to
understand the vulnerabilities of adolescent prefrontal cortex and the specific impacts of genetic and
environmental perturbations.
1

Public health relevance
PROJECT NARRATIVE Over the last 10 years, there has been an unprecedented advancement in our understanding of genetic and environmental risk factors for psychiatric disorders that typically emerge in adolescence, notably schizophrenia and bipolar disorder. Armed with a litany of potential disease mechanisms, there is an ardent need to understand the genetic code that regulates “neurotypical” adolescent brain development. For this project, we aim to define fundamental and human disease-relevant molecular mechanisms of adolescent development in the prefrontal cortex, a brain region that matures late in the second decade of life and serves cognitive functions that are disrupted in psychiatric disorders. We will generate gene expression data from the marmoset, providing a reference for the design and interpretation of genetic and environmental perturbations in this emerging psychiatric research model species. We will also compare gene expression data from mouse, marmoset, and human to identify features which may contribute to our species’ unique vulnerability to psychiatric disorders, and suggest potential therapeutic targets. 1